Elucidating mechanisms of active dendritic integration in vivo

Neural circuitry processes information at the cellular level by filtering, amplifying, and integrating electrical signals
generated and modulated by synaptic input and voltage-gated mechanisms. This project focuses on uncovering
the underpinnings of such processes using electrophysiology, two-photon imaging, and optogenetics. The key
aim is to understand the role of neuronal dendrites in processing information during in vivo circuit activity.
Dendrites can fire regenerative electrical spikes much like axons, and this potentially provides a critical aspect
to information processing at the cellular level. How such an active mechanism is engaged and plays a functional
role in a behaving animal remains unclear. By directly recording intracellular electrical activity from fine distal
dendrites and their parent somas during sensory processing in vivo, along with two-photon imaging of calcium
dynamics at synaptic inputs and dendrites, we seek to understand how active dendritic mechanisms contribute
to synaptic integration, and how their modulation affects sensory integration. In this study, we will address the
following questions in vivo: 1) What is the relationship between dendritic synaptic inputs and dendritic spiking,
2) how effective are dendritic spikes in triggering axonal action potentials, and 3) what is the functional role of
dendritic spikes in sculpting the receptive field properties of neuronal output. Findings from the project will both
further our understanding of the fundamental mechanisms of cellular information processing and provide a
foothold to decipher how neural circuitry is affected in conditions such as Alzheimer’s Disease and other
neurophysiological disorders.

Public health relevance
Project Narrative The studies proposed here will further elucidate subcellular mechanisms of single neuron computation. The results will provide detailed insights into postsynaptic mechanisms for input processing that allow for flexible toggling among different outputs in individual neurons. The findings from the study will not only contribute to our basic understanding of the computational capacity of the brain but will also aid in our understanding of subcellular dysfunctions in neurological diseases.